Administrative Core

CORE 1 – ADMINISTRATIVE CORE: SUMMARY
The overall goal of this P01 program project grant (PPG) application, titled ELEVATE, is to evaluate novel
therapeutic approaches for hepatocellular carcinoma (HCC) in pre-clinical models, with the ultimate objective
of transitioning these approaches to Phase I/II clinical trials. To achieve this, a team of investigators with robust
expertise in HCC, mouse modeling, cancer immunotherapy, nanoparticle-based delivery, and medicinal
chemistry will continue to collaborate on four highly integrated research projects. Core 2, the Mouse Model and
Pathological Analysis Core, will provide crucial support by generating essential mouse models to investigate
gene function and evaluate therapeutic responses. Additionally, Core 2 will provide critical analysis of tissue
samples to diagnose tumorigenesis and changes in response to treatment. Core 3, the Biostatistics and
Bioinformatics Core (BBC), will provide biostatistical and bioinformatics support across the projects. Given the
complex interactions among the four projects and two cores, the Administrative Core (Core 1) will provide
critical support to facilitate overall integration, planning, and management of the ELEVATE program. Core 1,
the Administrative Core, will 1) provide overall research direction and program oversight by setting the
research agenda focused on novel treatment approaches for HCC; 2) deliver general administrative and fiscal
management support, which will ensure effective and efficient intra- and inter-institutional communication,
coordination, and compliance with all terms and conditions of the grant; 3) promote communication and
integration within the program, facilitate constructive review and enhancement of the research progress
through frequent and deliberate interactions with expert External and Internal Scientific Advisory Committees
(ESAC and ISAC, respectively), and create and maintain a PPG website and secure portal for enhanced
communications and data sharing/dissemination by and among the research projects; and 4) facilitate and
promote collaborative science by organizing and coordinating annual retreats and symposia on HCC. Core 1
will ensure seamless collaboration among all components of the ELEVATE program to accomplish the overall
and specific project goals.

Public health relevance
CORE 1 – ADMINISTRATIVE CORE: NARRATIVE Core 1 will provide critical support to ensure the seamless integration and effective planning and management of the ELEVATE program. The core will oversee the overall research direction and fiscal management, ensuring accountability and compliance with all institutional, state, and federal requirements for grants management and resource sharing, to ensure that the program goals are met.